Microenvironmental Influences in Cancer

PROJECT SUMMARY
This application seeks continuing support for the Microenvironmental Influences in Cancer
Training Program (MICTP) at Vanderbilt University. Over the past 35 years, we have
successfully recruited and trained excellent students and postdoctoral fellows, including many
from groups underrepresented in science. Based on the strength of our training faculty, in the
next five years, we will focus on training our students and postdoctoral fellows in emerging
areas of the tumor microenvironment, including quantitative analysis of large datasets, tumor
immunology, influences of bone and bone marrow cells, hypoxia and blood vessel
normalization, spatial analyses of tumor interactions with the microenvironment, and
extracellular vesicles. Overall, the MICTP training program encompasses a group of 30 faculty
members from the Vanderbilt University School of Medicine who are experts on the tumor
microenvironment. The training program is conducted within a vibrant academic environment
and is supported by close interactions with the Vanderbilt-Ingram Comprehensive Cancer
Center. In addition to preceptor-specific laboratory instruction, each trainee receives program-
specific training in the form of (1) Topical workshops, which introduce trainees to emerging
fields of the tumor microenvironment; (2) Individualized training coursework that may include
“Cancer Precision Medicine” with individualized clinical experience, (3) a monthly T-32 Scientific
Forum with trainee works-in-progress talks and faculty presentations covering science and
careers, (4) an annual MICTP mini-retreat, and (5) a five-session grant workshop (6) Training in
Diversity and inclusion in collaboration with the Diversity office in the School of Medicine.
Faculty preceptors also receive mentorship training including “Culturally Aware Mentoring”.
Furthermore, predoctoral students are supported by an Interdisciplinary Graduate Program and
the Program in Cancer Biology. Postdoctoral trainees are supported by an institutional Office of
Postdoctoral Affairs, which provides both financial and academic support as well as career
development advice and career development opportunities. Vanderbilt University and the VICC
have committed a significant ongoing investment in training programs, core facilities, state-of-
the-art laboratories, and equipment that help create a rich training environment for our trainees.
Our program uniquely intersects with VU and VICC to provide training in a novel and critical
area to create an essential workforce to understand the complexities of the microenvironmental
influence on cancer development and progression, and to translate this information into more
effective and less toxic approaches to the treatment and prevention of cancer.

Public health relevance
PROJECT NARRATIVE One of the rapidly developing frontiers in cancer research is the tumor microenvironment. Training in this critical area of cancer research is necessary to build the workforce required to understand the complexities of the microenvironmental influence on cancer development and progression and to translate this information into more effective and less toxic approaches to the treatment and prevention of cancer.